ENHANCING THE CALERIE NETWORK TO ADVANCE AGING BIOLOGY

ENHANCING THE CALERIE NETWORK TO ADVANCE AGING BIOLOGY
ABSTRACT:
In direct response to PA-20-071, Advanced-Stage Development and Utilization of Research Infrastructure for
Interdisciplinary Aging Studies), we propose to enhance and grow the CALERIE Research Network into a self-
sustaining infra-structure of samples, data, and aging biology investigators. The Comprehensive Assessment
of Long-Term Effects of Reducing Intake of Energy (CALERIE) was a randomized controlled trial designed to
assess the effects in humans of two years of sustained caloric restriction without enforced changes of dietary
composition. The overall objective was to elucidate underlying biological mechanisms and mediators of
primary and secondary human aging. The rigorous design and execution of the CALERIE intervention
produced an invaluable resource, including comprehensive phenotypic data that are coupled to biological
samples. To ensure continued use of these samples and data, we describe a plan to create a self-sustained
CALERIE Network. Our aims are to advance aging research through enhanced 1) utilization, 2) development
and interdisciplinary growth of the CALERIE Research Network. Utilization of CALERIE resources will be
promoted and stewarded by a Steering Committee, an NIA Biobank representative, NIA-supported Networks
and Centers, annual workshops and working groups. These efforts will ensure best use of remaining CALERIE
samples as well as incorporation of new data into a complex multi-level database. CALERIE Network inter-
disciplinary growth will be fostered by attracting new and junior aging biologists to pilot projects, career
development activities, and a rich pipeline of integrative systems biology projects. By developing more
investigators, projects, and disciplines, new data and samples will be generated and will perpetuate the aging
biology scientific cycle. Thus, completion of these aims should yield a mature, sustainable infrastructure that
maintains and oversees CALERIE samples and data, perpetuates CALERIE ancillary integrative
investigations, and contributes to overall advancement of understanding of human aging biology.

Public health relevance
PROJECT NARRATIVE In a previously performed study, healthy persons were randomly assigned to two years of reducing calorie intake or continuing eating as usual. Results showed the low calorie group had superior benefits in multiple areas of aging-related health. Samples and data from this project remain available for additional studies to better understand calorie reduction effects. This proposal describes a plan to make the best possible use of these samples and data and also develop new investigators and projects in the area of aging.